Core A - Administrative Core

CORE A – ABSTRACT SUMMARY
The role of Core A (Administrative) is to provide leadership, promote cohesion, and ensure fiscal oversight for
the P01 Strategies for Targeting Reactive Astrocytes in AD and ADRD. En route to stimulating and fostering
interactions among the P01 team, Core A will provide common resources, manage budgetary issues, and fulfill
administrative obligations to the University and to the NIH/NIA. These services will allow the Projects and Cores
of the P01 to focus on the Science and reconceptualize the role of reactive astrocytes in the pathophysiology
of Alzheimer’s disease (AD) and related dementias (ADRDs). The Aims of Core A are: (1) Provide coordinated
and coherent infrastructure that enhances scientific activities. (2) Oversee animal colonies and
production/characterization of AAV reagents. And (3) provide fiscal management and administrative support.
The Administrative Core will facilitate timely and consistent oversight so that Projects and Cores can work
together as a unit to study reactive astrocyte signaling in ADRDs.